Structural Studies and Drug Discovery to Interrogate the Function of Neuronal SLC4 Transporters

PROJECT SUMMARY
Members of the SLC4 bicarbonate transporter family regulate cellular pH in essentially all tissues. Among
those, SLC4A7, SLC4A8, and SLC4A10 constitute the subfamily of electroneutral, Na+-dependent transporters
that are highly expressed in the brain. Control of cellular pH is not only important for essentially all cellular
processes, but it uniquely also directly governs neuronal excitability, making SLC4A7, SLC4A8, and SLC4A10
key regulators of neuronal signaling. Unsurprisingly, mutations of these transporters thus cause a variety of
neurological and neurodevelopmental disorders, and, for instance, loss of SLC4A10 function has been found to
cause intellectual impairment, anxiety, hyperactivity, and episodic seizures in children. Although these clinical
findings and studies in animal models highlight the importance of these transporters in human health and
disease, little is known about their molecular mechanisms. Moreover, no tool compounds are currently
available to further interrogate the function of SLC4A7, SLC4A8, and SLC4A10, and potentially explore
therapeutic avenues in seizure disorders and other illnesses. To address these shortcomings we herein
propose a multidisciplinary approach to combine insights from structural and biochemical studies, molecular
dynamics simulations, structure-based in silico drug development, and validation of probe activity in
(patho)physiologically relevant model systems. Our ultimate goal is to provide key mechanistic insights into
SLC4 substrate binding, transport and inhibition, and directly leverage these data in the development of useful
SLC4 tool compounds with different subtype-selectivity profiles. We specifically propose three independent
aims: (i) Elucidate the different substrate stoichiometries of SLC4A7, SLC4A8, and SLC4A10 using a
combination of cryoEM, computational approaches, and cellular transport studies; (ii) develop subtype-
selective and nonselective SLC4 tool compounds targeting substrate and allosteric binding sites via structure-
based computational drug discovery; and (iii) validate utility of novel probe scaffolds in primary neuronal
culture, human neurons derived from induced pluripotent stem cells, and brain slices using substrate uptake
assays and electrophysiological recordings. Together, our studies are poised to not only provide direct
fundamental insights into SLC4 structure and function, but also generate first-in-class probes with which to
explore therapeutic avenues at SLC4 in future studies.

Public health relevance
NARRATIVE The bicarbonate transporters SLC4A7, SLC4A8, and SLC4A10 are highly expressed in the brain where they not only regulate cellular pH homeostasis through Na+-coupled import of the base HCO3-/CO32-, but thereby also control neuronal excitability. Mutations in these transporters have been associated with numerous neurological and neurodevelopmental disorders including traits of autism spectrum disorder, as well as seizure disorders such as epilepsy. Our studies will provide fundamental mechanistic insights and generate first-in- class SLC4-targeted tool compounds that will pave the way to developing efficacious treatments for SLC4- associated disorders.